Real Time NEURON Simulation for Experimental Applications

The goal of this Phase II proposal is to combine the power of the NEURON mathematical modeling software with
the Cybercyte “plug and play” dynamic clamp system. The end product will be a user-friendly, powerful and
reliable way for a typical patch-clamp electrophysiologist to combine theoretical predictions and living cells
directly, in real-time, during an experiment. The NEURON-Cybercyte package will be a turn-key system which
enables neuronal electrophysiologists to be able to perform sophisticated NEURON model based dynamic clamp
experiments, without any requirement for programming, engineering, or mathematical modeling skills. Our
product is an integrated package of hardware and software specifically for neuroscience applications. Its ease
of use and simplicity is in automating the processes that ensure the stability and reliability needed for the large
array of ion channels, cell types, and neural circuits found in the nervous system. In Phase I, we demonstrated
proof of concept and built a prototype interface to enable NEURON models to interact through the Cybercyte
dynamic clamp system, with live experiments, in real time. In Phase II we will build on this work to optimize the
hardware, software, and databases in this package so that the user has a seamless, user-friendly experience.
The challenges we will overcome are combining cutting edge computational abilities from two different systems,
with an offline compendium of neuroscience knowledge. In the same way that AI creates presents a comfortable
interface for people to get answers to complex questions without any need for understanding the sophisticated
systems and databases underlying the interaction, we are creating a comfortable interface enabling users to
have computers converse with cells, without any need for any programming, engineering, or searching
databases. The four aims of this project are:
Aim 1: Expand and optimize the major applications of the NEURON-Cybercyte package: In this aim, we will
optimize the prototype to be able to work with the major applications of dynamic clamp, namely: A) electronic
expression of modeled currents into experimental cells; B) insertion of experimental currents into synthetic cells;
and C) cell to cell coupling with modeled synaptic transmission linking experimental cells.
Aim 2: Develop a library of tested models. This follows from the strong demand from our users and interviews
for a library of tested cellular models that are ready-to-use in one or more of the three modes described in the
first aim.
Aim 3: Develop a user toolkit. This user toolkit will enable rapid adaptation and testing of new and existing
NEURON models for integration into the Cybercyte system for experimental use. We will develop user
safeguards to allow relatively computationally naïve users to produce high quality data.
Completion of these aims will result in a commercial advanced dynamic clamp system with an interface to
NEURON, which is powerful, versatile, reliable, but plug and play to install, and simple to use.

Public health relevance
This project builds a special system that allows computer models to become integral parts of neurons in real time experiments. We can use the models to interacting with the neuron as it responds to stimuli, so we can better understand how and why some mutations or drugs cause seizures or other mental and neurological disorders. We can also use it to develop better medicines to treat disorders and have fewer side effects.